HSV Amplicon-mediated Disruption of Abeta Fibrillogenesis

DESCRIPTION (provided by applicant): Alzheimer's Disease (AD) pathogenesis has been linked to the abnormal processing of amyloid precursor protein (APP) resulting in excessive extracellular accumulation of Abeta peptide within plaque. In a pathogenic state Abeta entry into plaque must exceed its rate of removal. Peripheral vaccination with aggregated Abeta elicits an immune response resulting in reduction of apparent central nervous system amyloid by a mechanism that is presumed to involve CNS entry of antibodies and in situ removal from plaque. Humoral immunity has been implicated in this protective response, as some believe peripherally derived Abeta-specific antibodies act by altering Abeta equilibrium between the CNS and periphery thus preventing CNS deposition. The contribution of each of these processes may be a function of the type of antibody and its antigenic recognition properties. We hypothesize that immunization with forms of Abeta which undergo progressively enhanced degrees of fibrillarization will elicit immune responses against toxic higher-order Abeta structural intermediates that, in turn, will engender differential protection against disease pathogenesis. This application proposes to use a potent herpes virus-based vaccine strategy to determine the role of Abeta fibril formation in elicitation of strong anti-Abeta immune responses and how such host responses disrupt disease processes. Three aims are proposed. Characterization of fibrillar and non-fibrillar Abeta peptide-expressing; amplicon-based vectors. Amplicons encoding the wild-type sequence for Abeta1-40 will be constructed along with vectors encoding mutated forms of Abeta shown previously to more readily form fibrillar structures. All vectors will be assessed in vitro for expression, antigen presentation, transgene product fibrillarization, and transgene product cytotoxicity profiles. Assessment of amplicon vectors in C57BL/6J mice. In vivo analyses of these vectors in C57BL/6J mice will be undertaken, including the profile of humoral and cellular immune responses as well as any untoward effects Abeta immunization may impart on behavior in normal mice. Assessment of immunization strategy in murine models of AD: Amplicon vectors will be administered to Sw C57BL/6J, SwDI C57BL/6J, and Tg2576 C57BL//6J mice to examine efficacy of the approach. Abeta burden, levels, and effects on CNS in these mice will be assessed using immunological, biochemical, and behavioral methods. Overall, these studies will elucidate the role of fibrillarization in the genesis of disease and establish the utility of amplicon-based vaccination for AD.